Task 1: Evaluation and Testing Services (ETS) for Vaccines and Other Biologics

This contract provides for the administrative, management and technical support activities for vaccines and other biologics under the NIAID Preclinical Services for Evaluation and Testing Services (ETS) Program.